Exploring the implications of widespread decreases in dynamic blood flow to the retina and choroid in dry macular degeneration

Applicant: Edward F, Linton, MD is a fellowship-trained Neuro-Ophthalmologist with a long-term goal of
becoming an independently funded translational clinician scientist, advancing sight-saving research with
expertise in multimodal imaging and functional assessment of the optic nerve and retina. An over-reaching
goal is to restore function in patients with visual loss (rehabilitation) and to intervene in patients with
progressive forms of vision loss (prevention).
Introduction: Poor blood flow has been identified as a risk factor for blindness from age-related non-exudative
macular degeneration (AMD). To save vision, research in choroidal perfusion and its normalization is needed
in AMD patients. This will be accomplished using an imaging technique that measures the dynamics of ocular
blood flow, laser speckle flowgraphy (LSFG), to complement imaging of vascular structure, using Optical
Coherence Tomography Angiography (OCT-A). This will enable the identification and monitoring of patients at
high risk of progression to advanced stages of AMD, who will be candidates for emerging interventions to
increase blood flow. Precise understanding of blood flow in AMD patients is required to capitalize on these
treatments to prevent vision loss and restore function in the millions of Americans at risk. Our preliminary data
using LSFG in the choroid and retina in a retrospective case-control study showed that ocular blood flow is
reduced in large areas even in early and intermediate AMD, which agrees with previous literature.
Methods: This proposal centers on a cross-sectional study of patients with non-exudative age-related macular
degeneration in the early, intermediate and advanced stages, as well as a cohort of control subjects stratified
by age. Blood flow will be measured in across a wide area of retina, including the macula, with laser speckle
flowgraphy, using standard techniques and a novel approach with a wide field montage image. Blood flow will
be compared between controls and patients with AMD at each stage to test the hypothesis that blood flow is
measurably reduced in all stages of dry AMD, after controlling for other risk factors. Repeat variability of blood
flow measurements will be assessed in preparation for following patients longitudinally to assess risk of
progression as a function of reduced blood flow. To test the hypothesis that blood flow reduction may precede
structural changes in the retina, we will compare the areas of reduced flow to the corresponding locations of
retina containing photoreceptors, retinal pigmented epithelium and underlying choroid. Once we have
established baseline studies of the cohort of AMD patients and age-matched control subjects in the proposed
2-year CDA-1 study, we will plan to study these subjects longitudinally in a follow-on prospective cohort study,
which the applicant will be well positioned to perform as part of a future career development proposal (CDA-2).
Career Development: Formal training will consist of university coursework in biostatistics related to clinical
research design, as well as internet-based coursework in Python programming for data science, image
processing, and introductory deep learning. Weekly interactions with mentors will advance skills in the design,
execution, and coordination of clinical research, techniques for image analysis of OCT, OCTA, and LSFG, and
communication of results. Primary mentor is Randy Kardon, MD, PhD, a neuro-ophthalmologist and career VA
clinician scientist with specific expertise in structural, functional, and blood flow assessments of the retina and
optic nerve. Co-mentor Elliott Sohn, MD is a vitreoretinal surgeon-scientist with expertise in the role of the
choroid in the development of age-related macular degeneration, from genetics and histology to imaging
including sophisticated OCT analysis of the choroid. Co-mentor Jui-Kai Wang PhD is an engineer and research
scientist with expertise in developing deep learning approaches to ophthalmic image analysis. The mentors
and career development activities will ensure Dr. Linton’s success in carrying out the proposed study and in his
future career as a VA translational scientist.

Public health relevance
Age-related macular degeneration (AMD) continues to be a leading cause of irreversible blindness in veterans. This project addresses remaining gaps in AMD prevention and treatment by investigating blood flow to the eye with specialized imaging specifically to identify those veterans at higher risk of vision loss with low blood flow in the eye. This project will determine whether using laser speckle flowgraphy (LSFG) a type of non-invasive imaging that measures blood flow supplying the retina, can detect lower blood flow among patients with age-related macular degeneration. We will also determine how variable these measurements are so that we know what to expect when following veterans’ blood flow over time in the future. This will allow us to identify and monitor veterans who could be candidates for new treatments to increase blood flow to prevent vision loss from advanced AMD.